Mechanism of Fungal Virulence Inhibition by a Bacterial Peptide

PROJECT SUMMARY/ABSTRACT
Opportunistic human fungal pathogens cause serious diseases. As resistance to the current arsenal of antifun-
gals increases, there is an urgent need to develop new therapeutics. The goals of this application are to elucidate
how EntV, a peptide secreted by Enterococcus faecalis that shows promising efficacy in several animal models,
inhibits fungal pathogenicity and to develop derivatives with improved stability and activity. The central hypothe-
sis is that the hydrophobic nature of one alpha helix of EntV enables binding to a target associated with fungal
extracellular vesicles (EVs), interfering with the export of material associated with virulence. The rationale for
this research is that identification of the mechanism by which EntV inhibits the virulence of fungal pathogens will
lead to new treatment strategies, which are desperately needed. Aim #1 is to identify the characteristics of EntV
associated with antifungal activity. Based on recently published data showing that the seventh helix of EntV is
the source of antifungal efficacy, it is hypothesized that the hydrophobic nature of this helix is important, and that
antifungal efficacy can be improved by changes that increase hydrophobicity and stability. In this aim, a7 will be
modified using both random and rational design strategies and tested for antifungal efficacy, initially in biofilm
and C. elegans infection models. Promising candidates will be further tested in murine oropharyngeal candidiasis
(OPC), murine systemic bloodstream candidiasis, and rat venous catheter infection models. Aim #2 will elucidate
the mechanism(s) by which EntV inhibits fungal pathogenesis. Based on preliminary data showing EntV binding
to EVs, the working hypothesis for this aim is that EntV disrupts/interferes with the transport of material that
promotes fungal virulence. Goals for this aim include characterizing EntV-induced changes in EV number, dis-
tribution, and components, identifying the cell envelope component(s) to which EntV binds, and identifying and
characterizing strains and mutants that are no longer susceptible to EntV. Because of the serious and growing
morbidity, mortality and antimicrobial resistance associated with fungal infections, the investigation will signifi-
cantly and positively contribute to human health by providing new avenues for anti-fungal development. Addi-
tionally, the study will broadly impact knowledge in the fields of antimicrobial peptides, fungal pathogenesis, EVs,
and interkingdom microbial interactions. Finally, an antimicrobial mechanism of action that targets EVs and re-
sults in loss of virulence represents a conceptual innovation.

Public health relevance
PROJECT NARRATIVE Fungal infections resistant to current antimicrobials is a growing public health concern that has received much media attention. The proposed project seeks to address this problem by characterizing and further developing a novel therapeutic – peptides derived from a bacterial protein with efficacy against human fungal agents in multiple animal models. Specifically, the goals are to understand and improve the efficacious features of the peptide and elucidate its mechanism of action.